A novel mechanism for polyunsaturated fatty acid uptake and action in neutrophils

Project Summary / Abstract:
Neutrophils are a major type of leukocytes that play important roles in acute inflammation. They are typically
the first leukocytes to be recruited to inflammatory sites and can eliminate pathogens by multiple mechanisms,
including releasing neutrophil extracellular traps (NETs). Although neutrophils are important for normal immune
responses, particularly to microbial infections, they are also responsible for and/or contribute to many
inflammatory diseases, including myocardial ischemia-reperfusion injury (MIRI). In our preliminary studies, we
found that neutrophil-specific KO of LRP5 (Lrp5N) aggravates heart injury in the MIRI model by enhancing
neutrophil activation. Our preliminary results further indicate that LRP5 may function as a transporter for
polyunsaturated fatty acids (PUFAs) and is required for PUFA-mediated inhibition of mTORC1 signaling in
neutrophils. In this application, we plan to determine how LRP5 transports PUFAs and how important LRP5-
transported PUFAs are for the regulation of neutrophil activities and inflammation diseases related to
neutrophils, including MIRI.

Public health relevance
Project Narrative: The neutrophil is the most abundant white blood cells and plays critical roles in inflammatory diseases including various heart diseases. Polyunsaturated fatty acids (PUFAs), which include omega-3 fatty acids and are enriched in foods such as fish oil, are known to have beneficial effects on heart health, but how they protect hearts is not well understood. This study will shed lights into how PUFAs help to reduce inflammation pertinent to heart health.